Cortical dystonia of prematurity

PROJECT SUMMARY
Preterm birth is the most common cause of cerebral palsy (CP) in the US and, consequently, the most common
cause of childhood dystonia, a disabling condition affecting 2 of every 1000 Americans. Despite its high
prevalence, dystonia in CP remains difficult to treat because 1) it is hard to predict, preventing early treatment
when it is most effective; 2) its neuropathology after preterm birth is unclear; and 3) few treatment targets exist.
This proposal addresses these gaps by investigating a novel cortical cause of dystonia after preterm birth. We
and others have shown that striatal injury, namely chronic excitation of striatal cholinergic interneurons (ChINs),
causes dystonia. Yet, anticholinergic dystonia treatments are variably effective in CP, necessitating a search for
other treatment targets. We have shown that cortical injury, more than striatal injury, best predicts dystonia in
children born preterm. Cortical pathology is also seen in adults with non-CP dystonias who demonstrate
abnormal sensorimotor cortex inhibition, suggesting dysfunction of cortical GABAergic interneurons. The largest
class of these interneurons are parvalbumin-positive (PVINs). Our preliminary data show that chemogenetic
inhibition of sensorimotor cortex PVINs in mice causes dystonia and that mice born preterm have reduced cortical
parvalbumin immunoreactivity and fewer PVINs. Sensorimotor PVINs may cause dystonia via targeted
modulation of striatal ChIN activity. Sensorimotor PVINs inhibit glutamatergic cortical output neurons and striatal
ChINs receive glutamatergic cortical input. Yet, it is unknown if sensorimotor PVINs modulate striatal ChIN
activity via these excitatory corticostriatal neurons. These data support our central hypothesis: sensorimotor
cortex PVIN inhibition causes dystonia after preterm birth via striatal ChIN excitation. We will leverage
two of our recent scientific advances to test our innovative hypothesis: 1) our novel mouse model of preterm birth
that demonstrates dystonia by postnatal day 42, and 2) quantitative dystonia measures in mice that we
developed and clinically validated. In Aim 1, we determine whether cortical dysfunction precedes, and potentially
predicts, dystonia onset in mice born preterm by longitudinally assessing sensorimotor PVIN number and cortical
oscillatory activity using electroencephalography, and dystonic behavior using our innovative clinically-validated
dystonia measures. In Aim 2, we determine whether inhibition of sensorimotor PVINs excites striatal ChINs using
fiber photometry and chemogenetic inhibition of sensorimotor PVINs and corticostriatal neurons. In Aim 3, we
determine whether chemogenetic sensorimotor PVIN excitation can reduce dystonia in mice born preterm and
whether this chemogenetic treatment prior to dystonia onset at postnatal day 42 is more effective than treatment
after dystonia onset. These studies will establish the critical role of sensorimotor PVINs in dystonia prediction
(Aim 1), pathophysiology (Aim 2), and treatment (Aim 3) and provide the necessary foundation for future
translational studies testing cortically-targeted treatments for dystonia following preterm birth.

Public health relevance
PROJECT NARRATIVE Preterm birth is the most common cause of childhood dystonia, a debilitating movement disorder that is hard to treat. Dystonia treatments have focused on striatal injury, but our data show that cortical injury may be more predictive of dystonia following preterm birth. In this proposal, we use our novel mouse model of preterm birth and our clinically-validated dystonia quantification methods to investigate sensorimotor cortex parvalbumin- positive interneurons as a new cortical treatment target for dystonia following preterm birth.